FASEB SRC: The Trace Elements in Biology and Medicine Conference

PROJECT SUMMARY
The 2022 FASEB Conference on Trace Elements in Biology and Medicine will take place in Asheville, North
Carolina from June 12th to June 16th, 2022. This conference, the 16th iteration of this biennial meeting since
1983, is designed to bring together a diverse group of researchers to share and discuss the latest findings in
trace element research. Trace elements such as iron, copper, zinc, manganese, and selenium play critical
roles in biology, nutrition, and health as illustrated by the wide range of disorders and diseases associated with
imbalances in these essential micronutrients. A notable strength of this conference series has been its ability to
unite basic scientists focused on the molecular details of trace element homeostasis in diverse model systems
with clinical scientists/physicians studying the direct impact of trace elements on human health, nutrition, and
disease, thus bridging the gap between basic and applied science. By integrating molecular and biomedical
research, this conference has been highly successful in fostering fruitful collaborations across disciplines and
in identifying novel systems and approaches to solve problems related to micronutrients and health. The
program will span a range of scientific interests ranging from cellular and systemic trace element transport and
homeostasis, trace elements and disease, metal signaling, and nutritional aspects of trace elements. The
meeting also includes a careers workshop, a “meet the experts” event, and a poster blitz, which provide
opportunities for trainees and early career investigators to gain additional knowledge and cultivate professional
skills. The ultimate goal of this conference series is to foster the ongoing development of new therapeutic
treatments for disorders and diseases related to trace element metabolism.

Public health relevance
PROJECT NARRATIVE The 2022 FASEB Science Research Conference on Trace Elements in Biology and Medicine will bring together researchers performing the latest, cutting-edge research that advances our understanding of the roles of trace elements in biology, nutrition, health, and disease. Trace elements such as iron, zinc, copper, manganese, and selenium are essential for life, and imbalances in their uptake, distribution, storage, or excretion result in a large number of nutritional and metabolic disorders. This conference plays a critical role in bridging basic and applied research in trace elements and in training the next generation of scientists in this exciting and expanding field.